Characterizing pubertal and age mechanisms of neurodevelopment and association with rising internalizing symptoms

PROJECT SUMMARY
Building comprehensive accounts of human brain development from childhood to early adulthood is crucial to
our understanding of both healthy neurodevelopment and the mechanisms underlying threats to youths’ mental
health. Brain development unfolds on multiple levels, but the field lacks a comprehensive understanding of
whether the trajectories of development are fundamentally similar or different across modalities (e.g., structure
and function), and how they reflect developmental mechanisms associated with puberty or age (or both). The
proposed research aims to generate a systematic and comprehensive multimodal account of typical
neurodevelopment from ages 5 to 21, with a particular focus on a) identifying age versus pubertal- and
hormonal-based mechanisms that undergird development in childhood and adolescence; b) systematic
analyses across brain structure, function, and connectivity using state-of-the-art acquisition and analysis
approaches; and c) evaluation of maturational variation in multimodal coupling across brain systems/
modalities as a function of development. Once established, this multimodal model of typical neurodevelopment
will be used to test a conceptual model proposing that early pubertal timing leads to intensification of
internalizing symptoms due to disruptions in brain development, including alterations in multimodal coupling.
Specifically, models of the impact of early pubertal timing predict either further enhanced coupling with early
puberty (neurodevelopmental acceleration) or disruptions in coupling due to neurodevelopmental delays. To
compare these competing models and advance our understanding of the neurodevelopmental pathways by
which early pubertal timing contributes to the rise of internalizing symptoms during adolescence, the research
will use both hypothesis-driven methods and novel validated analysis pipelines for data-driven exploration of
developmental changes in coupling, with careful attention to robustness and replication. The primary dataset
will be the Human Connectome Project in Development (HCPD), a large, NIH funded, multimodal brain
imaging dataset that includes a comprehensive assessment of brain structure, function, and connectivity paired
with pubertal and hormonal measures and extensive behavioral and clinical measures in both a cross-sectional
cohort of N=1300+ youth ages 5 to 21, and a longitudinal cohort (N=252) spanning ages 9 to 17 capturing the
pubertal transition. This sample is purposefully strong diversity in race, ethnicity, and socioeconomic status.
Key findings will be replicated to ensure robustness and generalizability in the Adolescent Brain and Cognitive
Development (ABCD) longitudinal study. Our Specific Aims are to: A1) Establish a comprehensive, systematic
account of age-and pubertal-linked pathways of brain development across multiple modalities of brain structure
and function; A2) Test hypotheses about the relations of age and pubertal development to coupling across
brain modalities; and A3) Test hypotheses about the neurodevelopmental mechanisms contributing to the rise
in internalizing symptoms during the pubertal transition.

Public health relevance
PROJECT NARRATIVE The proposed research will use two of the largest datasets on child and adolescent neurodevelopment in existence to inform how puberty influences the development of the brain and emerging risk for mental illness. Using measures of puberty and hormones, paired with multiple metrics of brain development, we will disentangle the relationship between age, puberty, and hormone concentrations and brain development, and establish how different measures of brain development interrelate across puberty. In addition, we will examine the neurodevelopmental mechanisms that help explain why early puberty increases an individual’s risk for mental health problems including depression and anxiety.